Identify and Evaluate Potential Risk Factors for Amyotrophic Lateral Sclerosis - A Unique Contribution from Sweden

Project summary
Military service, traumatic brain injuries (TBI), chronic neuroinflammation and infections have all been suggested
as potential risk factors for amyotrophic lateral sclerosis (ALS). The currently existing knowledge base is however
limited by systematic and random errors. Moreover, the underlying mechanisms linking together those risk
factors and the initiation and progression of ALS are still largely unknown.
With the ultimate goal of providing important new knowledge for disease prevention among high-risk individuals
and identifying novel therapeutic targets, the overarching aim of this research program is to use the extensive
data and biospecimens collected in a unique Swedish national ALS registry, to identify and evaluate military
service, TBI, mental disorders (as a proxy for chronic neuroinflammation), and infections as potential risk and
prognostic factors for ALS, focusing on understanding their interactions with individual genetic susceptibility to
ALS, chemical exposures (>10,000 chemicals and their metabolites measured in human tissue), and gut
microbiome. We will replicate some of these findings in the Agency for Toxic Substances and Disease Registry
(ATSDR) implemented US National ALS Registry where we have already collected samples from ALS patients.
In the specific Aim I, we will assess the roles of military service, TBI, mental disorders and infections on the risk
and prognosis of ALS, using prospectively and independently collected data from the Swedish national health
registers (including the Motor Neuron Disease [MND] Registry), by contrasting ALS patients of different clinical
phenotypes with three control groups, namely disease-free full siblings, spouses, and age- and sex-matched
population controls. In the specific Aim II, we will characterize the role of interactions between different
exposures and 1) individual genetic susceptibility to ALS, 2) chemical exposures, and 3) gut microbiome on ALS
in Sweden and replicate findings in the United States. In the specific Aim III, we will develop a molecular
phenotyping-based precision medicine tool to allow precise stratification of ALS patients based on their
exposome, genetic susceptibility to ALS, and clinical measures, to provide a novel approach to better predicting
disease progression.
Findings from this project are expected to advance our understanding of ALS as a disease and provide new
knowledge for disease prevention and treatment, fully supporting the ATSDR National ALS Registry's mission.
The findings will also help ATSDR better prioritize topics for future research initiatives and inform the
development of new ATSDR ALS Registry risk factor surveys for persons with ALS.

Public health relevance
Project narrative Undisputedly, ALS is one of the worst diagnoses for doctors to give, and for patients to receive, due to its rapid progression and the current lack of therapeutic options. Identification of potential non-genetic risk factors for ALS, especially the modifiable ones, is therefore of paramount importance in providing new knowledge for disease prevention among high-risk individuals and identifying novel therapeutic targets. Hence, this project aims to use high-quality epidemiological research resources in Sweden and the United States, in combination with state-of-the-art molecular technologies and data science, to identify and evaluate potential risk factors for ALS, focusing on characterizing how and why the risk factors are associated with ALS and contribute to the etiology, progression, and pathophysiology of ALS, in humans.